University of Michigan Anesthesiology Post-Doctoral Research Training Program

PROJECT SUMMARY / ABSTRACT
The University of Michigan (U-M) is one of the largest and most highly ranked public universities in the country,
as well as a major center for graduate and post-graduate research training. The Ann Arbor campus is home to
19 schools and colleges, and U-M faculty and learners embody multidisciplinary training and research. With
more than $1.7B in annual research expenditures, U-M is the top public university in research spending in the
United States; more than half a billion of annual awards go to the Medical School. Within this broader
environment of excellence, the U-M Department of Anesthesiology has reached an unprecedented level of
research success, as evidenced by increased NIH awards (#1 ranking for anesthesiology departments for
seven consecutive years) and millions of dollars annually from non-NIH source; increased quantity and quality
of publications; high-level institutional research roles; and national research leadership in fields (such as
precision health, pain and opioids, consciousness, and data science) that transcend the traditional boundaries
of the field. The department has a created a nurturing environment for developing a diverse research workforce
and the anesthesiology T32 training program has become the centerpiece of our career development pathway.
Our T32 graduates are successful academic anesthesiologists and scientists with independent federal funding.
Moreover, some are leading multidisciplinary and multicenter research teams. We have created a training
program that balances individual T32 fellow needs with structured training and processes to ensure a sound
foundation for innovative science. Using our institutional and national leadership roles, the T32 fellows gain
expert perspectives from different fields and different institutions. We have objectively enhanced the diversity
of our applicants and trainees. In the next phase of the T32, we are focused on i) continuing to develop and
launch careers of academic anesthesiologists and scientists in anesthesiology-related fields; ii) continue to
increase the diversity of our applicant and graduate pool, iii) creating national reach and impact for our
scholars, iv) disseminating our training resources broadly using modern hybrid learning approaches, and v)
expanding training to address modern professionalism standards. We are committed to helping diverse
clinician-scientists become outstanding, professional, and ethical leaders, nurturing mentors, and innovators
who contribute to the public good through a positive impact on health, science, and society.

Public health relevance
PROJECT NARRATIVE The University of Michigan T32 postdoctoral training program in anesthesiology will benefit public health by developing a diverse, ethical, and professional research workforce that addresses the scientific underpinnings of health problems related to surgical care, critical care, and pain management.